TCR signaling in thymic selection: Role of innate immune activation

Summary
The thymus plays a critical role in preventing autoimmunity by deleting or inducing a Treg cell
fate in thymocytes that react to self-antigens present in the thymus. But it is unclear how the
thymus achieves tolerance to transiently expressed self-antigens, like those expressed in
induced immune states such as inflammation, wound repair, and germinal center reactions. We
have recently discovered that the thymus constitutively produces type I and III interferons and
class switched activated B cells, beginning quite early in life. Our published and preliminary data
show that these cytokines activate antigen presenting cells in the thymus environment and
cause reproducible changes in the T cell repertoire selected, particularly the Treg cell repertoire.
Thus, we seek to test the hypothesis that T cells need to be highly tolerant of induced immune
states (inflammation, germinal centers) in order to function in those states without inducing
autoimmune pathology.
The proposed research will: 1) Test if thymic IFN provides T cell tolerance to interferon
stimulated self-antigens, 2) Determine why IFNI/III deficient mice have a major thymic selection
defect, and 3) Test if IFNIII-licensed B cells select Treg cells that regulate humoral immune
responses.
These aims will provide a mechanistic understanding of the source and consequences of innate
immune activation in the thymus. Understanding T cell tolerance to self-antigens in immune
activated states is important because many human autoimmune diseases are associated with
or follow infections.

Public health relevance
TCR signaling in thymic selection: Role of innate immune activation Narrative Human autoimmune disease arises from failures of tolerance induction in the thymus. This proposal will study a fundamental property of how tolerance is induced in the thymus, namely the role of innate immune activation of antigen presenting cells.